Decoding Enzyme Sequence-Activity Relationships via Generative AI for Rational Enzyme Design

Project Summary
Rational enzyme design holds the promise to transform biological research and therapeutic development by
enabling the creation of efficient biocatalysts. However, current methodologies in rational enzyme engineering
remain limited; computationally designed enzymes often fall short of natural enzymes and require extensive
experimental optimization. A fundamental barrier to progress is the incomplete understanding of enzyme
sequence-activity relationships. In fact, even the most advanced data-driven and physics-based models cannot
reliably and systematically predict mutation effects on enzyme activity. Such a prediction is critical for designing
optimal enzyme sequences for efficient catalysis. This limitation underscores the need for novel approaches.
Generative AI offers a compelling solution to overcome the barrier, analogous to how language models like
ChatGPT interpret semantics in human language. Generative AI can learn from sequences evolved in nature to
predict protein function. In particular, the PI has pioneered the application of generative AI to predict enzyme
activity using sequence data. Our research has demonstrated that natural sequence information can reliably
predict the impact of mutations on enzyme catalytic activity, especially in active sites, enabling the successful
optimization of multiple enzymes in biochemical assays. Additionally, we found that loop sequence within TIM-
barrel scaffold enzymes can predict novel activity when integrated into de novo designs. These insights represent
a new paradigm for studying enzyme catalysis, highlighting how different enzyme regions are evolved for
catalytic efficiency in nature. This research program aims to further advance our understanding of enzyme
sequence-activity relationships through generative AI, with the long-term goal of achieving fully rational enzyme
design. In Direction 1, we will evaluate the generalizability of these relationships across diverse enzymes, laying
the groundwork for future sequence-based enzyme engineering. Directions 2 and 3 will overcome the current
limitations of black-box AI models by incorporating physics-based modeling to elucidate the sequence-activity
relationships identified by generative AI. Specifically, Direction 2 will investigate how active sites are
preorganized for efficient catalysis. Direction 3 will explore the role of loops in TIM-barrel enzymes and develop
strategies to enhance catalytic activity by engineering these loops. Overall, this proposal aims to introduce
innovative methodologies to link enzyme sequences with their catalytic activities, deepen our understanding of
enzyme catalysis, and pave the way for fully rational enzyme design.

Public health relevance
Project Narrative The potential of rational enzyme design is vast in reshaping biotechnology and therapeutics, yet predicting mutations that enhance enzyme activity is challenging. The increasing availability of natural enzyme sequences, analyzed through generative AI, shows significant promise in connecting sequence information to enzyme activity. This proposal aims to leverage generative AI and physics-based modeling to unravel nature’s strategies for evolving enzyme, driving advancements in both enzymology and enzyme engineering.